Center for AIDS Research at Emory University

Modified Project Summary/Abstract Section

This application is for the competitive renewal of the Center for AIDS Research at Emory University (Emory CFAR). Since first funding in 1997, the Emory CFAR has risen to preeminence in the HIV research community, through the development and support of its members. Emory CFAR Members possess broad expertise representing the full scientific spectrum needed to accelerate HIV science from the bench to the bedside to the communities we serve. Emory CFAR organizes this expertise into five research focus areas: Basic Research, Pre-Clinical Research, Clinical Research, Prevention Science, and Public Health. These focus areas are served by an Administrative Core, a Developmental Core, five Science Cores (Biostatistics and Bioinformatics; Clinical Research; Prevention and Implementation Sciences; Systems Immunology; and Virology and Molecular Biomarkers); and two Scientific Working Groups (SWGs). The Emory CFAR is uniquely poised—geographically and scientifically—to achieve our mission. We are located at the epicenter of four high burden counties as defined by Phase I of the Ending the HIV Epidemic Initiative. These metro-Atlanta counties are home to almost 3.5M persons, representing one-third of Georgia's population. Our physical location allows CFAR Members to apply the scientific tools necessary to achieve the EHE goals and advance the NIH research priorities. Given the high burden of HIV in our geographical region, coupled with gaps in access to healthcare in the communities we serve, the Emory CFAR is committed to ensuring broad access to research, faculty development, and community engagement. We will intentionally seek to recruit and develop a cadre of early career investigators in collaboration with our colleagues at Morehouse School of Medicine, and we will continue to elevate the role of the CFAR Community Liaison Council, expanding their influence within the CFAR to guide best practice for the dissemination of HIV research findings and together, we will strive to build community trust in research. The Emory CFAR proposes the following Specific Aims: Aim 1. Advance groundbreaking HIV research across the entire scientific spectrum of NIH-defined priority research areas to end the epidemic for all. Aim 2. Cultivate cutting-edge tools and services to support transdisciplinary research teams. Aim 3. Develop and train the next generation of outstanding HIV investigators. Aim 4. Elevate multidirectional community engagement to improve the well-being of people living with and at risk for HIV across their lifespan.

Public health relevance
Modified Public Health Relevance Section The Emory CFAR will contribute to ending the HIV epidemic by accelerating the highest caliber translational research — fostering team science and multidirectional stakeholder engagement. We will strive to build community trust in research through the active participation of key stakeholders at all stages of the research pipeline. We will achieve our goals by providing innovative services, tools, expertise, and access to state-of-the-art equipment through an Administrative Core, a Developmental Core, five Science Cores (Biostatistics and Bioinformatics; Clinical Research; Prevention and Implementation Sciences; Systems Immunology; and Virology and Molecular Biomarkers); and two Scientific Working Groups (SWGs).